Epidemiology of Plasmodium vivax in Ethiopia in varying Duffy Phenotypes

Project Summary
This is an application for a F31 Fellowship for Lauren Bradley, a PhD student trainee under the sponsorship of
Dr. Guiyun Yan, Professor of Public Health at the University of California Irvine, and co-sponsorship of Dr.
Christopher King, Professor of Global Health at Case Western Reserve University. The overall goal of this
fellowship is to seek support for Miss Bradley to conduct PhD thesis research in malaria epidemiology, and
cultivate her scientific skills to become an independent researcher in the field of global health. The specific
objectives include: 1) Designing epidemiological studies and conducting molecular population genetic analysis
to test hypotheses related to Plasmodium vivax malaria infections in Duffy-negative human residents in rural
Africa; 2) Develop competency in epidemiology and bioinformatics to analyze large sets of genomic data; 3)
Gain leadership and professional skills necessary to develop a career in global health and lead diverse and
interdisciplinary research teams. Plasmodium vivax malaria is the most geographically widespread human
malaria, and is responsible for tremendous human suffering and reduction in economic productivity. Africans or
people with African ancestry are thought to be protected from P. vivax infection because their lack of Duffy
antigen expression on the surface of the erythrocytes renders P. vivax parasites unable to invade the
erythrocytes. Interestingly, recent studies reported P. vivax infections in Duffy-negative Africans. Therefore, the
scientific objective of this F31 application will focus on molecular epidemiology and population genetics of P.
vivax malaria in Africa. In Aim 1, Miss Bradley will use cross-sectional surveys, a longitudinal cohort study, and
passive case surveillance to examine the relationship between malaria exposure, Duffy genotypes and malaria
burden in vivax endemic Ethiopia. In Aim 2, she will conduct population genetic and bioinformatic analyses of
P. vivax from Duffy-negative and Duffy-positive individuals through microsatellite genotyping and amplicon
next-generation sequencing. This research will significantly improve the understanding of the mechanisms for
the spread and transmission of vivax malaria in Africa, and provide important baseline data to monitor changes
over time in vivax malaria prevalence and incidence that result from control measures or environmental
changes in understudied African regions of Ethiopia. Through this proposed research and training, Miss
Bradley will gain skills in epidemiology, population genetics and bioinformatics, and develop professional and
leadership skills necessary to prepare her for a career in global health and infectious disease research. This
project is leveraged on the malaria surveillance system, infrastructure, data management established by a NIH
supported malaria center grant, to ensure the success of the proposed research and training plan.

Public health relevance
Project Narrative Malaria remains a major public health concern in Sub-Saharan Africa, yet infection from Plasmodium vivax remains relatively rare compared to the more deadly and endemic P. falciparum. Historically lack of P. vivax on the continent has been credited to the near fixation of the Duffy negative blood type, common among ancestral Blacks, which offers blood stage immunity to P. vivax infection; yet in recent years P. vivax infections have been found in Duffy negative individuals in various African countries. Better understanding how these infections are occurring, and determining if P. vivax is evolving around this molecular immunity is vital to determining the threat of P. vivax infection proliferation and spread on the African continent.